Targeted Exosomal Delivery of siRNA Therapeutics for Neuroinflammatory Diseases

Technical Abstract
Neurodegenerative disorders affect over 40 million people worldwide and most, if not all, are mediated by
inflammation. Even though several drugs have recently been approved by the FDA for treating neurological
disorders including Alzheimer's disease (AD), their efficacy as AD therapeutics has not been realized as extremely
low levels of the drug reach the brain. The goal of this Phase I project is to develop an effective targeted delivery
system for siRNA against NFκB expression (siNFκB) to mitigate neuroinflammatory diseases. We have recently
shown that siRNA entrapped in bovine colostrum-derived exosomes and polyethyleneimine matrix (EPM) can
effectively deliver siRNA to reduce target gene expression. We will apply our extensive experience in exosomes,
siRNA therapeutics and inflammatory responses for efficient, targeted delivery of siNFκB to the microenvironment
of the brain where progressive increase in inflammation ultimately leads to manifestation of neuroinflammatory
diseases including AD. We hypothesize that EPM-siNFκB formulations administered via a novel trans-spinal (t.s.)
route can effectively deliver siNFκB to the brain and knockdown the inflammatory regulator NFκB and attenuate
corresponding disease markers. We also hypothesize that use of smaller exosomes (smExo) (average size 45
nm) coupled with folic acid (FA)-functionalization can enhance the brain delivery presumably due to more efficient
crossing of the blood brain barrier and high expression of folate receptor-α (FRα) in the brain, respectively. Our
hypotheses are supported by high siRNA entrapment (>90%) in the EPM, protection of EPM-siRNA from
enzymatic degradation, higher knockdown of NFκB in murine cells than conventional reagents, higher brain
accumulation of smEPM-siRNA in mice treated via t.s. route compared with the traditional routes, intravenously
and intranasally, and FA-functionalization of exosomes for brain targeting. Innovation in this project lies in the use
of bovine colostrum powder - an abundant and cost-effective source of native exosomes, use of smaller exosomes
and FA-functionalization coupled with t.s. administration. Investigators experienced in exosomes, drug delivery,
siRNA therapeutics and animal models, leveraging extensive experience of Dr. Robert Friedland in AD research,
will pursue the following specific aims: Aim 1. Optimize delivery of siNFκB using FA-functionalized exosomal
vector in vitro and in vivo. Murine cell lines bearing WT sequences of NFκB will be used to identify effective siNFκB
sequences based on NFκB knockdown. Aim 2. In vivo efficacy of brain-targeted FA-smEPM-siNFκB. The lead
formulation from Aim 1 will be tested for efficacy in murine models of AD. Therapeutic benefit will be based on
knockdown of NFκB in the target (cortex and hippocampus) and non-target tissues, related histopathological and
AD biomarker changes, and assessment of behavioral endpoints. This project will provide proof-of-principle for
inhibition of neuroinflammation by targeted t.s. delivery of siNFκB. In Phase II, we will compare inhibition of other
targets such as BACE1, a key target for AD, alone and in combination with NFκB using multiple rodent AD models
to identify the optimal gene target(s) for this disease.

Public health relevance
Narrative (Public Health Relevance Statement) In the proposed project, we will use a novel nano formulation of small interfering siRNA to mitigate neuroinflammation and attenuate neurological diseases including Alzheimer's disease (AD). In our approach, siRNA of the key inflammation regulator, NFκB (siNFκB) is sequestered in exosomes (native nanoparticles) isolated from standardized bovine colostrum powder, the exosomes are attached to folic acid to target the brain sub tissues such as cortex and hippocampus, and the formulation is delivered trans-spinally by topical application for efficient brain targeting. The novel formulation will be optimized using mouse cell lines and the trans-spinal delivery system tested using mouse models for inflammation and AD.